Path B State of Alaska, Department of Environmental Conservation (DEC), Enhance Produce Safety through a Quality Regulatory Program, and by Providing Education and Technical Assistance

Grant Number TBD
Alaska Department of Environmental Conservation
The FDA's Cooperative Agreement Program for States and Territories to Implement a
National Produce Safety Program PAR-21-174
Project Period: 2021-2026
Project Summary/ Abstract
The State of Alaska, Department of Environmental Conservation is applying for Program PATH B.

Public health relevance
Grant Number TBD Alaska Department of Environmental Conservation, PATH B The FDA's Cooperative Agreement Program for States and Territories to Implement a National Produce Safety Program PAR-21-174 Project Period: 2021-2026 Project Narrative The implementation of the Produce Safety Rule (PSR) is one important element in creating the proactive and preventive food safety system envisioned by the Food Safety Modernization Act (FSMA). This project is designed to assist the FDA in advancing efforts for a national integrated food safety system (IFSS) by enhancing produce safety and achieving high rates of compliance with the PSR by way of a state regulatory program in Alaska focused on quality and national consistency, as well as education and technical assistance for growers. At the conclusion of this cooperative agreement we anticipate having a developed, sustainable Alaska Produce Safety Program; a farming community educated on the requirements of the PSR and good agricultural practices; a fully-verified inventory of Alaskan produce farms; a high- quality inspectional program consistent with national practices; developed protocols for compliance and enforcement activities; and protocols and partnerships in place to respond to emergency situations such as outbreaks and recalls. Additional information is included under the attachments for Specific Aims and Project Plan.